Research Project 1

PROJECT SUMMARY
Colorectal cancer (CRC) is exerting a significant public health impact in Mexico despite the availability of
effective screening strategies. Yet, there are no national CRC screening (CRCS) guidelines or organized CRCS
programs in Mexico. We aim to implement a CRCS program in an integrated health system that is context-
appropriate, sustainable, scalable, and easily transferable to different health systems in Mexico. We will
optimize FIT uptake and CRCS completion by adapting and evaluating evidence-based interventions (EBIs)
(patient education, patient reminders, patient navigation); designing implementation strategies (training with
technical assistance, practice champions, audit and feedback) to deliver these EBIs; and evaluating the
effectiveness, cost-effectiveness, and implementation outcomes using a type 2 hybrid effectiveness
implementation study. Our proposed research is potentially groundbreaking and of substantial public health
significance in that it will be the first implementation research study in Mexico to address CRCS while applying
rigorous implementation science methods. It will advance scientific knowledge on the effectiveness of EBIs that
have been developed and tested in other countries and adapted for use in Mexico; it will also study the impact
of implementation strategies to deliver them in a real-world setting. Our proposed study will incorporate an
economic evaluation of the implementation of the EBIs to provide healthcare institutions with the necessary
information to plan for adoption and sustainability in settings with different resources.